EO14042 NIDDK: DEVELOPMENT OF AN ELECTRONIC CARE PLAN FOR PERSONS WITHMULTIPLE CHRONIC CONDITIONS (E-CARE)

EO14042 NIDDK: DEVELOPMENT OF AN ELECTRONIC CARE PLAN FOR PERSONS WITHMULTIPLE CHRONIC CONDITIONS (E-CARE)